Cytotoxicity and function of incomplete proteins

PROJECT SUMMARY / ABSTRACT
Rationale: All cells produce incomplete proteins, a consequence of surprisingly common errors in gene
expression. Cells have evolved multiple mechanisms to suppress expression of incomplete proteins, including
the degradation of mRNAs containing premature stop codons (nonsense variants). Such nonsense-mediated
mRNA quality control occurs in both prokaryotes and eukaryotes. The bacterial process is grounded in
premature termination of transcription by Rho and subsequent RNA degradation, a mechanism reliant on tight
coupling of transcription and translation. The existence and apparent universality of nonsense-mediated quality
control has been taken to suggest that incomplete proteins are highly cytotoxic. However, this proposition has
not been systematically investigated. Furthermore, recent work from the Li lab has revealed that a broad swath
of bacteria – notably B. subtilis and other Firmicutes (Bacillota) – altogether lack nonsense-mediated quality
control and transcription-translation coupling. In other recent work, I developed an approach for massively
parallel measurements of bacterial growth inhibition by complex libraries of protein fragments, derived from
array-synthesized oligonucleotides. This methodological innovation provides the previously missing tool
needed to systematically investigate cytotoxicity of incomplete proteins. In this proposal I bring together these
conceptual and technological breakthroughs, along with computational analyses and other complementary
methods, to address fundamental questions about the physiological impacts of incomplete proteins and the
importance of their suppression. I hypothesize that most incomplete proteoforms are innocuous, but a subset
are cytotoxic, and that B. subtilis protein sequences have evolved to limit truncated variant toxicity. I will also
investigate the contributions of incomplete proteins to bactericidal activity of ribosome-inhibitory antibiotics, and
the evolutionary pathways enabled by a lack of suppression of premature stop codon mutants.
Objective: To address these questions, I will systematically define the cytotoxicity of incomplete proteins by
measuring growth rate effects of incomplete proteins from across the B. subtilis and E. coli proteomes,
determining protein features associated with cytotoxicity, and further investigating physiological effects of
select proteoforms using ribosome profiling, RNA sequencing, and pull-down mass spectrometry. I will also
determine how incomplete proteins contribute to bactericidal activity of ribosome-inhibiting antibiotics by
combining translatomic and proteomic measurements of drug-induced incomplete protein production with
massively parallel cytotoxicity measurements. In a third approach, I will redefine the functions and evolutionary
roles of pseudogenes in Firmicutes by using a knockout library to demonstrate premature-stop pseudogene
function and employing bioinformatic analyses to determine the prevalence of duplication and truncation as a
path to novel genes. Finally, I will use a high-throughput assay to systematically map the landscape of
potentially beneficial truncation variants.

Public health relevance
PROJECT NARRATIVE All cells produce a contingent of incomplete proteins due to surprisingly common errors in gene expression, and mechanisms exist to suppress these truncated protein variants, suggesting that they are highly cytotoxic; however, this proposition has not been systematically tested. In the proposed work, I will harness a powerful new method for massively parallel measurements to determine the cytotoxicity of incomplete proteins across proteomes. Combined with complementary techniques, this approach will allow me to address fundamental questions regarding the importance and function of nonsense-mediated quality control mechanisms, the roles of incomplete proteins in the bactericidal activities of antibiotics, and the evolutionary consequences of suppressing incomplete protein-coding mutations, with implications for the 10-15% of human diseases linked to premature truncation variants.